Adjuvant comparison for pertussis vaccines

The objective of the project is to compare adjuvants that induce distinct immune profiles in the context of pertussis antigens in a baboon model of pertussis.